Mechanisms associated with flares and remission in colitis

Summary
Inflammatory bowel diseases (IBD) affect millions of individuals worldwide and its incidence is increasing. Both
genetic and environmental factors appear to play a role in IBD development. Genetic studies in humans have
linked the interleukin-23 (IL-23) signaling pathway with IBD, but the environmental factors contributing to disease,
have remained elusive. The rising incidence of worldwide IBD has been associated with westernization of dietary
habits in developing countries, however there is little scientific evidence to support causality. In this application
we will examine the role of a particular group of dietary additives, namely food colorants, to development of
colitis. We have now discovered that the food colorant Red 40, also known as Allura Red AC, promotes colitis
in mice that conditionally express low levels of IL-23 (referred to as R23FR mice), but not in wild type mice. Red
40 is the most abundant food colorant in the world, with annual production exceeding 2.3 million kg. It is widely
used in as red colorant in soft drinks, cherry flavored products, candy, dairy, drugs, and cosmetics. Of interest,
the Red 40-containing beverages, Kool-Aid and the hydrating solution Pedialyte Cherry can also cause colitis in
R23FR mice. Red 40-induced colitis in R23FR mice requires the microbiota and CD4+ T cells. Based on these
and other results presented here, we formulate a central hypothesis that the Red 40 or its metabolites haptenize
bacterial or endogenous proteins to generate tolerance in wild type mice, or colitis in mice in which IL-23
expression is dysregulated. We will study in this proposal the mechanisms involved in generation and prevention
of these responses. Specifically, we will define: 1) if Red 40 and its metabolite ANSA are haptens; 2) how Red
40 induces tolerance in control mice; and 3) if Red 40 or ANSA-specific T cells are generated in R23FR mice

Public health relevance
NARRATIVE One of the great challenges of modern medicine is to understand how environmental factors, such as diet, contribute to the increasing incidence of inflammatory and autoimmune diseases. We have recently discovered that the food colorant Red 40, the most abundant food colorant in the world, may be an important factor contributing to this phenomenon. Under normal conditions, consumption of this product does not induce disease, but if it is coupled to abnormal expression of the immune hormone IL-23 in mice, it can lead to development of intestinal inflammation that has many similarities with human IBD. In this application we describe a research project to study how one environmental factor (the food colorant Red 40) interacts with IL- 23, intestinal bacteria, and immune cells to cause intestinal inflammation.